Artificial Intelligence-based & Ethically-focused Multi-Modal Data Integration Framework for Screening, Diagnosing, and Caring for CKD Patients

Abstract
We will develop a distributed, cloud-based, artificial intelligence (AI) tool for the prediction of
chronic kidney disease (CKD) progression and modifiable risk factors for clinical use. Our tool will
provide a 5-year risk profile individualized to each patient and will integrate electronic health
record (EHR) data, text data, radiology images with corresponding reports, and pathology data,
including brightfield histology images and electron microscopy reports. The EHR, text, laboratory,
and radiology data from >200K individuals with kidney disease will drive the AI tool development
supplemented with histopathologic image data from >1000 individuals. Although histopathologic
information has long held prognostic significance for end-stage renal disease, such data is rarely
included in clinical kidney failure risk equations due to its complexity. Because the histopathologic
manifestations of CKD are broadly distributed across the kidney’s functional units, our tool will
facilitate the decomposition of each kidney whole slide image into hundreds of sub-images,
comprising >~3M functional units, quantitate pixel-level features, and provide balance among the
different modalities for effective learning and generalization. The resulting tool will support:
primary care physicians and nephrologists who will benefit from enhanced risk prediction using
complex data types, patients who will benefit by identification and prioritization of modifiable risk
factors, and nephropathologists who will benefit from the quantitative analytics. An iterative
process will incorporate their feedback to enhance the usability and usefulness of our platform.
Our platform will be self-adapting, and will ingest and learn from new data as it evolves, improving
kidney disease trajectory prediction and therapeutic care.

Public health relevance
Chronic kidney disease (CKD) affects more than 35 million Americans and is a leading cause of kidney failure and cardiovascular disease. This project develops and evaluates an artificial intelligence tool that integrates clinical, imaging, and molecular data to improve prediction of CKD progression, support earlier and more personalized interventions, and enhance communication of risk to patients and clinicians. By improving risk stratification and clinical decision-making, this work aims to reduce the public health burden of CKD and improve long-term patient outcomes.